Molecular Devices for the Detection and Treatment of HCMV Infection

PROJECT SUMMARY
CMV disease is the largest cause of post-transplant patient mortality. After a transplant, patients have to
undergo extensive screening and prophylactic therapy in order to prevent reactivation of the virus. In many
cases, even if these precautions are taken, the virus will reactivate after the patients finish antiviral therapy. This
is due to the virus establishing latency in cells of the myeloid lineage. Because the antivirals target and inhibit
virus replication, CMV is very difficult to target in its latent stage due to low levels of replication. This proposal
aims to develop molecular tools that have the potential to be used in clinic to prevent CMV-related mortality, by
combining the fields of protein and DNA engineering.
In the first aim, a CMV detection platform will be developed that combines the techniques of rolling circle
amplification and hybridization chain reaction to then turn on a luminescent protein biosensor that can be
detected with a cell phone camera. This tool will allow identification of active CMV infection with high sensitivity
by performing the one-pot reaction at room temperature with no special equipment for detection other than a cell
phone. Patients will be able to self-screen at home using this low-cost alternative to PCR that does not require
trained personnel or expensive equipment.
In the second aim, DNA self-assembly technique of toehold-dependent strand displacement will be
utilized to trigger a toxic protein switch in response to CMV-specific RNA input. The components will be
introduced into a population of cells that may be latently infected with CMV, and the switch will turn on in response
to a latency-associated CMV RNA that is expressed in target cells. This will cause specific death of CMV-infected
cells. The potential application of this switch is its use in bone marrow transplants—the switch may be introduced
in the cells of donor bone marrow, and any infected cells can be killed before transplantation into the recipient.
Development of DNA/RNA-activated protein switches have been limited to natural cas proteins so far.
There is a strong desire for the discovery of more cas proteins to extend the toolbox of CRISPR. The techniques
developed in this proposal will circumvents that need by “CRISPR-izing” proteins of choice to perform any desired
function based on a nucleic acid input. In aim 1 of this proposal, an RNA-activated luminescent protein switch
will be constructed, and in aim 2, an RNA-activated toxic protein. These findings will give rise to a new class of
proteins to perform functions unattainable by cas proteins in nature.

Public health relevance
PROJECT NARRATIVE CMV has a high global prevalence and is the leading cause of transplant related mortality. The proposed research will combine tools from DNA and protein based synthetic structural biology to construct (i) a biosensor that will allow transplant patients to self-screen for CMV at home, and (ii) a protein switch that will use CMV’s genetic signature to kill virally infected cells. This is the first attempt at combining technologies from two separate fields that have evolved independently, and the outcome of this project will pave the way for the construction of biomolecular switches using this hybrid approach for applications beyond the reach of each individually.